Building Capacity to Meet the Palliative Care Needs of People with Parkinson Disease, Lewy Body Dementia and Related Disorders living in Black and Hispanic Communities

PROJECT SUMMARY/ABSTRACT
Parkinson's disease (PD), Lewy Body Dementia (LBD) and related disorders are the second most common
neurodegenerative illness affecting over 1.5 million Americans and are the 14th leading cause of death in the
United States. Notably, while PD is traditionally described by motor symptoms (e.g. tremor), more recent
research demonstrates that nonmotor symptoms (e.g. pain, depression, and dementia) are leading causes of
mortality, diminished quality of life, nursing home placement and caregiver distress. There is significant evidence
that many needs most important to patients and family are poorly addressed under traditional care models and
that palliative care—an approach that addresses multiple causes of suffering including medical symptoms,
psychosocial issues and spiritual needs—may improve relevant patient and caregiver-centered outcomes.
Unfortunately, progress in this field threatens to increase rather than diminish disparities in care. While mounting
research shows palliative care improves outcomes in PD, these studies have largely failed to reach or include
underserved populations. Studies to date have not dedicated sufficient resources to counter known disparities
in neurology and palliative care, nor have they utilized appropriate community engagement methods to overcome
key barriers. This R34 planning grant represents the first step of community-based health equity research to
develop and assess culturally-tailored approaches to improve equity in neurology palliative care research and
will lay the groundwork for future community-engaged clinical trials. This project reflects ongoing work from a
multidisciplinary team composed of academic and community members to explore how to modify current models
of palliative care in PD to be culturally sensitive, accessible, scalable, and integrated into healthcare institutions
and systems serving the Black/African American and Hispanic communities. Notably, interest in this topic was
generated by our Community Advisory Board and reflects their perception of pressing gaps in neurologic and
palliative care services. Our Specific Aims are to: 1) Strengthen existing academic-community collaborations
centered on palliative care for PD and LBD in Black and Hispanic communities through principles of Community-
Based Participatory Action Research (CBPAR); 2) Conduct qualitative assessments using CBPAR to identify the
most important palliative care needs of Black and Hispanic communities, information gaps, and preferences for
receiving supportive care; and 3) Work with national leaders in community engagement around PD and LBD to
develop plans, processes and infrastructure to be ready to engage in multisite clinical trials of palliative care for
people with PD in Black and Hispanic populations. This research is Innovative as it represents the first
applications of CBPAR to move towards equitable care and research in neurology. This research is Significant
as it stands to improve person and family-centered care for a leading neurodegenerative illness, will lead to more
equitable clinical trials, and its findings and methods will create a foundation for other neurologic illnesses.

Public health relevance
PROJECT NARRATIVE While there is growing evidence to show that palliative care improves outcomes in patients and carepartners affected by Parkinson's Disease (PD), Lewy Body Dementia (LBD) and related disorders, studies have largely failed to reach individuals living in Black/African American and Hispanic communities. This R34 planning grant will build capacity for novel methods and collaborations to improve access and utilization of palliative care for PD and LBD in Black/African American and Hispanic communities through Community-Based Participatory Action Research (CBPAR) and collaborations with other national leaders. Specifically, this planning grant's multidisciplinary team of academic and community members will explore how to modify current models of palliative care in PD to be culturally sensitive, accessible, scalable, and integrated into current healthcare institutions serving the Black/African American and Hispanic communities and will develop needed infrastructure to launch future multisite community-engaged clinical trials.